Informing optimal first-line antihypertensive therapy: A rigorous comparative effectiveness analysis of ARBs vs. ACEIs on long-term risk of dementia, cancer, heart disease, and quality of life

PROJECT SUMMARY
Hypertension (HTN) prevalence increases with aging and is a leading risk factor for several chronic illnesses
including Alzheimer's disease and related dementias (ADRD), cardiovascular disease (CVD), and several
cancers, as well as mortality. Angiotensin II receptor blockers (ARBs) and angiotensin-converting enzyme
inhibitors (ACEIs) are two of the most commonly prescribed anti-HTN classes, used by ~40 million US adults.
ARBs and ACEIs and have distinctive beneficial downstream effects on physiologic abnormalities in HTN,
including vasoconstriction, inflammation, fibrosis, and oxidative stress, which in turn may result in different
long-term risks of ADRD and multimorbidity associated with aging. However, current HTN guidelines
recommend prescribing ARBs and ACEIs interchangeably due to presumed equivalent benefit and safety. Our
goal is to optimize initial anti-HTN medication prescribing by clarifying the optimal first choice RAS-blocker
between ARBs vs. ACEIs. Because ~23 million US adults are currently taking an ACEI and physiologic
evidence supports differences in downstream effects of these medications, even if ARBs are only 15% more
effective, the long-term population health impact of switching first-line RAS-blockade from ACEI to ARB would
be enormous. We will leverage data from the Veterans Health Administration (VHA) and Kaiser Permanente
Southern California (KP SoCal) to evaluate the effects of ARBs vs. ACEIs on the risk of ADRD, multimorbidity,
frailty, and health-adjusted life expectancy (HALE; the amount of time one can expect to live accounting for
one's cumulative morbidity burden). The VHA and KP SoCal are ideal data sources to perform this research
because they include comprehensive healthcare information for >10 million patients, collect detailed
information on medication use and health outcomes, and have high patient retention with >10 years of follow-
up. The specific aims are to determine long-term comparative effects, including duration of use, of ARB- vs.
ACEI-based anti-HTN medication regimens on (Aim 1) the incidence of ADRD, CVD (stroke, myocardial
infarction, coronary revascularization, or heart failure), and cancers, separately and (Aim 2) the patient-
centered outcome of frailty and the population-centered outcome of HALE. We will use an active comparator,
new-user design accounting for medication adherence, as well as natural language processing to ascertain
ADRD more accurately in the electronic health record over using administrative codes alone. Our team is well-
suited to perform the study given considerable prior experience analyzing VHA and KP data, including
pharmacoepidemiologic analyses of anti-HTN medication use; assessment of ADRD, CVD incidence, cancer
incidence, and multimorbidity; and application of causal inference methods. Our project could support a
paradigm shift of first-choice RAS-blockade. Current projections indicate that ADRD will affect >115 million
people by 2050 and cancer incidence will be 27 million per year by 2040. The potential public health benefit of
addressing these knowledge gaps and, thereby, improving the quality and length of life is enormous.

Public health relevance
PROJECT NARRATIVE Hypertension prevalence increases with aging and is a leading risk factor for chronic illnesses including dementia, cardiovascular disease, and several cancers, as well as mortality. Angiotensin II receptor blockers (ARBs) and angiotensin-converting enzyme inhibitors (ACEIs) are two of the most commonly prescribed antihypertensive medication classes, used by ~40 million US adults, and are often prescribed interchangeably despite different beneficial effects on physiologic abnormalities in hypertension. In this study, we will use national Veterans Health Administration and Kaiser Permanente Southern California data to determine the long-term comparative effects of ARBs versus ACEIs on the risk of dementia, cardiovascular disease, cancer, frailty, and life expectancy accounting for level of illness and quality of life.